HIV-1 Intasome Assembly and Function

PROJECT SUMMARY / ABSTRACT
New HIV-1 infections continue to drive a worldwide pandemic. Combinatorial anti-retroviral therapies (cART)
have helped to blunt the clinical outcomes of HIV-1 infected individuals. However, drug-resistance mutations
continue to challenge cART regimens underscoring the importance of identifying new viral drug targets.
HIV-1 integration into the human genome is essential for a productive infection. Integration is catalyzed by the
retrovirus encoded integrase (IN) that forms a complex with the long terminal repeat (LTR) ends of the viral
cDNA, produced by reverse transcription of the HIV-1 genomic RNA. The resulting intasome precisely positions
the LTR-ends for catalytic strand-transfer into a genomic target site. Structural comparisons show that all seven
retrovirus genera maintain a central Conserved Intasome Core (CIC) containing a tetramer of IN. Some
retrovirus family members expand the structure surrounding the CIC by appending additional IN subunits. For
example, the prototype foamy virus (PFV) intasome assembles into a simple IN-tetramer while the mouse
mammary tumor virus (MMTV) forms an IN-octamer by attaching IN-dimers to either side of the CIC. IN octamer,
decamer, dodecamer (12-mer) and hexadecamer (16-mer) intasomes have been reported for HIV-1.
Remarkably, the contributions of IN-multimer architecture to HIV-1 biology is largely unknown.
The IN-assembly progressions that result in a fully formed HIV-1 intasome are similarly unknown. During
infection, reverse transcription and intasome assembly occurs at or near the nuclear membrane. The host
cofactor LEDGF/p75 appears to facilitate chromatin localization of the HIV-1 intasomes, and deletion of
LEDGF/p75 reduces HIV-1 integration at least 10-fold. We have found the non-conserved peptides linking well-
known conserved IN domains control HIV-1 IN-multimer architecture, and that LEDGF/p75 is necessary for
efficient HIV-1 intasome assembly in vitro. These observations underpin several key unanswered questions:
What are the factors that guide IN multimer progressions resulting in a fully assembled HIV-1 intasome? What
is the function of LEDGF/p75 in HIV-1 intasome assembly and/or chromatin interactions? How does HIV-1 IN-
multimer architecture impact genomic target site selection in cellulo?
We propose to utilize innovative real-time single molecule imaging and analysis to understand the contributions
of IN-multimer architecture on HIV-1 mechanics with the following Specific Aims: 1.) determine the IN assembly
progressions that control HIV-1 intasome architecture, 2.) determine the role of HIV-1 intasome architecture on
the dynamic interactions with defined target DNA and chromatin in vitro, and 3.) determine the role of HIV-1
intasome architecture on targeting host chromatin features in cellulo.
These studies are designed to interrogate the animated processes that support HIV-1 intasome architecture
with the goal of identifying additional retroviral progressions that might be exploited as therapeutic targets.

Public health relevance
PROJECT NARRATIVE Retroviruses must integrate into their host’s genome to cause a variety of devastating diseases including AIDS (HIV-1) and leukemia (HTLV-1). Integration is catalyzed by a complex between the viral integrase (IN) protein and the viral cDNA (termed an intasome), that for HIV-1 assembles with 12-16 IN subunits. The goal of this proposal is to quantitatively determine the biophysical rules that guide HIV-1 intasome assembly progressions as well as the effect of HIV-1 IN-multimer architecture on host genome integration.